Project 2 - Cell of origin contributions and vulnerabilities in clonal hematopoiesis

Project Summary
Heterogeneity within the hematopoietic stem cell (HSC) compartment is well defined and we
hypothesize may contribute to the wide range of phenotypes emerging from initiation of clonal
hematopoiesis (CH). This project will use distinctive tools for assessing cell state in the context
of Tet2 deletion to determine how the epigenetic and transcriptional program of the cell of origin
affects clonal dominance. These data will provide insight into the mechanisms of clonal
dominance and may offer epigenetic signatures indicative of risk for subsequent validation. We
will also focus on the metabolic state of dominant CH to define whether features of those cells
render them vulnerable to low intensity intervention. Successful accomplishment will guide
strategies for selective depletion of aberrant dominant clones.